Sinai diabetes center

PROJECT SUMMARY
Sinai Chicago (Sinai) is Illinois’ largest private safety-net healthcare system, serving
predominantly low-income communities of color with large Medicaid-eligible populations
in Chicago. In response to high diabetes rates and community calls for coordinated,
multidisciplinary diabetes care, Sinai designed the Center for Diabetes and
Endocrinology (the Center) which launched in 2020. The Center uses a comprehensive
model with streamlined services to address the full spectrum of patient medical and
non-medical needs. We propose a convergent mixed-methods optimization study to
determine the appropriateness and fidelity of three intervention components of a team-
based care model for patients served by the Center to define the ideal sequence for
improving patient outcomes. Grounded in qualitative methodology and guided by a
sequential multiple assignment randomized trial (SMART), we propose evaluating the
appropriateness of novel intervention enhancements (Aim 1); measuring fidelity of new
intervention enhancements (Aim 2); comparing the effectiveness and determining
optimization of intervention enhancements (Aim 3). We will evaluate Aim 1 via key
stakeholder interviews and focus groups. We will analyze Aims 2 and 3 by conducting
descriptive statistics on all variables, giving special attention to outlier values. We will
also run bivariate and multivariate analyses across variables of interest and time points
to determine the optimal sequence of intervention activities. We will disseminate our
learnings broadly to key stakeholders through community forums, peer-reviewed
publications and presentations. Our multi-disciplinary team has a wealth of experience
in health services programming as well as research and evaluation. We propose a 3
year, $1.5 million project from March 2023 to February 2026.

Public health relevance
Program Narrative Unlike a randomized control trial, our design seeks to draw causal inferences about the impact of varying the sequence of three TBC enhancements: small-group diabetes self- management training (DSMT), technology-supported remote glucose monitoring (RGM), and high-touch, individualized community health worker (CHW) support. Having better knowledge of how enhancements operate and their individual and combined impact on diabetes outcomes for people with a greater risk for poor diabetes control, is vital in ensuring limited resources are applied in ways that enhance efficiency, reduce costs, and improve patient outcomes and patient/provider experience. Second, the proposed study will examine the appropriateness, utilization and impact of novel technology to facilitate diabetes management and care in a safety-net hospital setting. Third, we aim to assess the potential for a high-touch, individualized CHW enhancement to improve uptake and adherence to DSMT and RGM among patients who do not improve within six months. This CHW innovation leverages persons particularly close to the population served who have the potential to strengthen intervention packages cost-effectively.